Flipped Germinal Centers

PROJECT SUMMARY
Developing universal vaccines to influenza and HIV-1 is an urgent global goal. A critical challenge is that
immune responses to native HIV-1 envelope (Env) and influenza hemagglutinin (HA) are dominated by non-
neutralizing and highly strain-specific antibodies. Discoveries that some individuals produce broadly
neutralizing antibodies (bnAbs) invigorated hope that, while not naturally dominant, broadly protective antibody
responses are possible. Antibodies mature during through somatic hypermutation (SHM) and affinity-based
selection in germinal centers (GCs) in competition with other antibodies that recognize different parts of the
same virus. It is widely believed that a prime and boost vaccine tactic can effectively elicit bnAb precursors and
strategically guide SHM trajectory can produce bnAbs. Challenges to this process are that native envelope
proteins may not bind well to the bnAb precursor antibodies and may be poorly represented in the antibody
repertoire. A strategic prime and boost strategy requires generation of designer viral envelope variants that
bind well to bnAb ancestor antibodies acting as a primer, followed by modified variants to function as boosting
immunogen(s) to shepherd bnAb maturation. This promising approach is hindered by time and effort required
to identify Env or HA variants as immunogens, which traditionally require mutation library generation, in vitro
static selection, cloning, expression, and validation testing. This extensive hands-on trial and error process
greatly hinders the pace of progress. Here a new technology is proposed with power to explosively accelerate
the pace of immunogen discovery by creatively harnessing the full spectrum of automated mutation and
selection inherent in one of nature’s innovations in hyperevolution—namely the GC SHM and affinity
maturation system—an automated in vivo dynamic mutation process coupled to parallel selection activity that
dynamically shuttles superior binding variants back for further diversification and selection. In addition to
dramatically improving binding affinity, the GC system can be engineered to generate new recognition. The
objective is to create flipped GC systems in which antibody genes are replaced with viral envelope proteins—
and deploy them for immunogen design. In contrast to dynamic antibody evolution to viral envelop protein in
normal GCs, flipped GCs dynamically evolve viral envelop protein toward user-defined antibodies (e.g. select
bnAb precursors and intermediates). The overall hypothesis is that, in the context of key modifications, the
GC/affinity maturation system is sufficiently flexible to permit bioengineered viral envelope proteins to affinity
mature toward user-defined bnAb precursors and intermediates. The objective will be pursued with two aims:
1) to establish parameters to engineer GCs as a platform for non-Ig protein evolution. And 2) to generate HIV-1
and influenza envelop variants from flipped GC mice. Completion of this work has potential to result in both
scientific and technological breakthroughs of broad impact because it is expected to define parameters
enabling the extension of the power of GC evolution beyond Ig to essentially any protein-protein interaction.

Public health relevance
Project Narrative The germinal center (GC) reaction is a remarkable feature of adaptive immunity that harbors a process of mutation and selection of antibodies, but its utility beyond antibody maturation to generate enhanced binding to antigen has not been explored. The proposed research will engineer flipped germinal center reactions, where antigen is mutated toward user-defined antibody binding. This is relevant to public health because it is expected to provide breakthrough technology for vaccine and biological drug design in addition to having a substantial impact on our understanding of fundamental principles underlying GC immunology.